Studying Aggregation in Neurodegenerative Disease using Synthetic Proteins

Summary/Abstract
Protein misfolding and aggregation to form fibrils are common features of neurodegenerative diseases, including
Alzheimer's disease (AD), Parkinson's disease (PD) and related diseases such as PD with dementia (PDD),
dementia with Lewy Bodies (DLB), and multiple system atrophy (MSA). Drugs that reverse or block protein
aggregation, combined with early diagnosis, provide the prospect for a cure that preserves the patient's memories,
personality, and control of bodily function. To design such drugs and diagnostic agents, one must understand the
process of aggregation within neurons and propagation to “infect” new neurons in order to identify the most
relevant targets for imaging and intervention. Our study will focus on the accumulation of fibrillar aggregates of
α-synuclein (αS), commonly associated with PD, and tau, commonly associated with AD. In many cases,
copathology of αS and tau is observed, blurring the classical boundaries between these diseases and demanding
a more detailed understanding of aggregation mechanisms. Tau and αS are both meta-stable proteins that can
form toxic oligomers and fibrillar aggregates under pathological conditions, including states of aberrant oxidative
stress or post-translational modification (PTM). However, in spite of much study, the causes of tau coaggregation
under pathological conditions remain unclear. We will investigate the molecular basis for tau fibril seeding by
select αS fibril strains. Specifically, we will test two hypotheses: 1) Direct physical interactions between αS fibrils
and tau monomers lead to tau aggregation; and 2) αS fibrils cause changes in cell signaling and/or mitochondrial
function that indirectly trigger tau aggregation. In order to probe these hypotheses and determine their relative
impact, we will perform cell-based studies in which tau aggregation is seeded with in vitro pre-formed fibrils (PFFs)
or amplified, seeded fibrils (ASFs) templated from AD, PDD, DLB, or MSA patient material. Probes attached to
αS, tau, and other key proteins will be used to track localization in fluorescence microscopy studies and identify
physical proximity using photocatalytic labeling. This will allow us to determine how αS fibril interactions in cells
lead to tau aggregation by first identifying the relevant proteins as well as their PTMs, and then observing their
colocalization with live cell imaging using non-perturbing fluorescent amino acid tags. Our studies will draw
important connections between AD related diseases (ADRDs), which typically feature tau pathology, and the
synucleinopathies, PDD, DLB, and MSA. These findings will provide key mechanistic insight into ADRD/PD
comorbidities and have the potential to identify new therapeutic targets that can prevent the triggering of tau
pathology in response to αS aggregation.

Public health relevance
Project Narrative The aggregation of proteins into neurotoxic oligomers (clusters) and ultimately into fibrillar tangles plays a pivotal role in the progression of Alzheimer's disease (AD), Parkinson's disease (PD), and related dementias. The proposed research will study the interactions of these protein aggregates to gain insight into the mechanism of their aggregation and the propagation of pathology from cell to cell, with a particular focus on the copathology of proteins traditionally associated with either AD or PD.